Mechanistic assessment of retinal ganglion cell genesis

Project Summary/Abstract
Retinal ganglion cells (RGCs) connect the eyes to the brain. They are essential for vertebrate vision as the sole
output neuron of the retina and are the pathogenic targets in glaucoma. A key goal of vision scientists is to fully
understand the factors required for RGC development, so these cells can be generated in vitro for cell
transplantation or replaced through dedifferentiation of existing cells. RGC genesis begins with transient
expression of the proneural basic helix-loop-helix protein ATOH7 in a subpopulation of early retinal progenitor
cells, which give rise to the 7 major cell types of the retina. Despite its broad lineage, only RGCs absolutely
require ATOH7 for their genesis as its loss of function causes optic nerve aplasia and severe secondary
retinovascular malformations. Interestingly, overexpression of ATOH7 can only generate ectopic RGCs from
certain lineages. Why do only some ATOH7+ cells become RGCs? Downstream of ATOH7 in the RGC lineage
are POU4F2 (BRN3B) and ISL1, two transcription factors that are also required for RGC development. Ectopic
expression of both Pou4f2 and Isl1 in the Atoh7 lineage are required to induce RGC development in Atoh7
mutant mice, suggesting a shared gene regulatory network that connects Atoh7, Pou4f2, and Isl1. What are the
downstream targets necessary for proper RGC development in the absence of ATOH7? By exploiting three
related but non-contingent aims, we propose to investigate the shared cis-regulatory elements and target genes
of Atoh7, Pou4f2, and Isl1 along with identification of potential cofactors influencing Atoh7+ cell fate decisions
during RGC genesis. First, we will apply a multi-species approach to test Atoh7, Pou4f2, and Isl1 co-regulated
cis-regulatory elements identified by our independent, integrated multi-omic analysis for: A) The spatial-temporal
expression pattern (zebrafish) of each transcriptional regulatory element and B) the necessity of each element
to activate target gene transcription (mouse) to determine precisely how each component contributes to the
dynamic tissue and cellular expression pattern of each target gene. Second, we will investigate the sufficiency
of each Atoh7, Pou4f2, and Isl1 target gene to influence RGC development in wild type and atoh7 mutant
zebrafish retinae. Third, we will use two transgenic mouse lines in a new experimental paradigm to isolate the
proteome of Atoh7+ retinal progenitor cells and evaluate changing Atoh7 protein-protein interactions as they
shift dynamically over the course of RGC genesis. These data will define key mechanisms controlling the
RGC gene regulatory network: 1) the onset of retinal neurogenesis and RGC fate specification; 2) the changing
retinal proteome and Atoh7 protein-protein interactions; and 3) identify new mechanisms for the generation of
RGCs in vitro for cell transplantation or new ways to induce RGC regeneration through dedifferentiation of native
retinal cells.

Public health relevance
Project Narrative We will investigate the retinal ganglion cell (RGC) gene regulatory network and proteomic environment essential for RGC genesis, differentiation, and survival to better understand critical mechanisms for RGC cell replacement or regeneration in optic neuropathies and glaucoma. The project, which uses mutant and transgenic mice and zebrafish, will advance the NEI goals to understand genes contributing to disease mechanisms, the biology and neuroscience of vision, and regenerative medicine, by studying genes linked to each of these areas of emphasis. Advancement in our understanding of the key RGC gene regulatory network transcription factors Atoh7, Pou4f2, and Isl1, and the essential RGC proteome, will increase knowledge on fundamental processes vital to RGC development, growth, and survival, filling an unmet need and help researchers to achieve the objective of restoring vision in RGC degenerative diseases.